PILOT--BREAST ONCOLOGY

The Breast Oncology Program (BOP) is a comprehensive program in breast cancer research encompassing basic research, clinical research and behavioral research. The program consists of 29 members from nine different departments and three schools within the University of Michigan, receiving over $4.4 million in annual direct support. Many members of this program also hold joint membership in one of the other Cancer Center basic science or prevention programs, including Cancer Genetics and Virology, Cancer Cell Biology, Tumor Immunology, Experimental Therapeutics, and the Biomedical and Socio-Behavioral Prevention Programs. These appointments further the program's goals of integrating fundamental basic research into the causes and prevention of human breast cancer with translational studies applying these research findings towards the diagnosis and therapy of breast cancer. In addition, funded research is being carried out to address issues of quality of life from breast cancer patients and their families. This program, which was rated as Outstanding at the last core grant review, has continued to make significant strides over the past five years in each of its research goals.